CLINICAL STUDIES OF NEUROGENETIC DISEASES

The clinical study of neurogenetic diseases provides the context in which the goals of improved diagnosis and potential treatment modalities are identified. Several new phenotypes have been recognized including a number of cases of deficiency of hexosaminidase A presenting as motor neuron disease; glycerol kinase deficiency presenting as acidemia and stupor without mental retardation; and biopterin deficiency presenting as familial dystonia. A number of rare phenotypes have also been identified including Tay-Sachs disease in a young non-Jewish child, 2 cases of juvenile Krabbe's disease, an unusual presentation of multiple sulfatase deficiency, an unusual case of San Filippo A disease, a mild variant of Morquio's syndrome, a case of arylsulfatase activator deficiency, a case of Menke's disease in a female infant, and several cases of acute neuronopathic Gaucher's disease. A large number of typical neurogenetic diseases have been confirmed by studies performed in this protocol. Studies of chorionic villus samples (CVS) have allowed the prenatal diagnosis of a number of lysosomal storage diseases. We have developed an accurate method for biochemically distinguishing phenotypes pre-symptomatically. Finally, a clinical trial of enzyme replacement is being conducted in Gaucher's disease. The application of gene transfer to human disease is under consideration.